Genomics-Accelerated Discovery and Biosynthesis of Phosphonic Acid Natural Products

PROJECT SUMMARY (UNCHANGED)
Microbial phosphonic acids are a class of understudied natural products with significant utility in medicine. The
antimicrobial, antiviral, and antimalarial activity of many useful phosphonic acids derives from potent and
specific inhibition of metabolic enzymes through chemical mimicry of their natural substrates. These properties,
along with the trove of novel biosynthetic gene clusters encoded within microbial genomic datasets, highlight
their potential of phosphonic acid natural products new antimicrobials. In this project we focus our efforts on
realizing their genomic potential of these compounds by establishing fundamental genetic and biochemical
principles that define their biosynthetic and bioactivity landscape. Filling these gaps in knowledge will provide a
systems-level understanding of natural product biosynthesis necessary to improve discovery and engineering
of new phosphonic acids. Specifically, we investigate three recently discovered phosphonic acid peptides to
uncover unusual hydroxylation, reduction, amination, and amino acid ligation enzymes, and the molecular
basis of their antimicrobial activity. We expand and refine the framework for phosphonic acid natural product
genomics through the isolation of new compounds from cryptic gene clusters, discovery of new pathways and
enzymes for C-P bond formation, and the development of a classification scheme to improve prediction of
phosphonic acid gene clusters and their chemical products.

Public health relevance
PROJECT NARRATIVE (UNCHANGED) The spread of antimicrobial resistance is global threat to human health that necessitates the urgent development of new antibiotics. In this we utilize genomics accelerate the discovery and characterization of phosphonic acids natural products, compounds with significant potential as future antibiotics. Our research will provide important answers to questions on how Nature makes these compounds and deliver a steady stream of new molecules with properties useful to antibiotic drug development.